Regulation of cytoplasmic dynein in vivo

Project Summary/Abstract
We study a microtubule motor called cytoplasmic dynein-1 (or “dynein” for simplicity). In
eukaryotic cells, microtubules serve as tracks for motor proteins such as dynein and kinesins to
move on. These motor proteins deliver cargoes, including organelles, vesicles, proteins, and
mRNAs, to different cellular locations for function. A microtubule has two different ends: the plus
end facing cell periphery and the minus end close to the cell center. Dynein is a minus-end-
directed motor, and it transports cargoes from the cell periphery toward the cell center. Besides
the physiological cargoes including early endosomes and other organelles/vesicles, dynein also
transports virus particles inward after viral infection. Our lab uses a filamentous fungus called
Aspergillus nidulans as a genetic system to study how dynein activities in live cells are
controlled by other proteins. We and other scientists have found that dynein gets transported by
a kinesin to the microtubule plus end where it interacts with early endosome via adapter
proteins such as the HookA complex and the dynactin complex. In live cells, these adapter
proteins are required for activating dynein to move toward the microtubule minus end. However,
this process also requires other proteins such as LIS1 (Lissencephaly-1) and VezA (a vezatin-
like protein). LIS1 promotes an “open” conformation of dynein to facilitate its activation, but the
mechanism of VezA is unclear. Our preliminary data also suggest that negative regulators are
needed to prevent dynein from moving away from the plus end prematurely without carrying its
cargo, but the negative regulators remain to be identified. Moreover, it is unclear what factors
regulate cargo release at the microtubule minus end. In the next five years, we will combine
classical genetics, live cell imaging with whole genome sequencing to identify both positive and
negative regulators of dynein activities. We will also use live cell imaging, proteomics and
structural analysis to solve the mechanisms of VezA and newly identified regulators. The
Aspergillus genetic system is best suited for these studies. While in vitro experiments are
excellent for studying known proteins, our genetic system has the power for discovering
unknown regulators. Discovering these regulators will pave the ways leading to new areas of
research in the field, which will stimulate further work involving collaborations to gain
mechanistic insights into the intricate regulation of the dynein motor.
.

Public health relevance
Project Narrative The project is focused on the in vivo regulation of cytoplasmic dynein, a motor that drives many cellular cargoes. In elongated cells such as neurons, long-distance cargo transport by dynein is critical for cell survival, and dynein deficiencies cause devastating neurodegenerative diseases, for example, Amyotrophic lateral sclerosis (ALS). Dynein is also important for brain development. Deficiencies in the dynein regulator LIS1 cause a brain developmental disorder called “lissencephaly” manifested by mental retardation and early death. Elucidating the regulatory mechanism of dynein will potentially benefit the development of therapies for these human diseases